Structure and dynamics of meiotic chromosomes

Abstract
This revision includes a request for undergraduate student funding only and will not result in changes to the
original proposed work

Public health relevance
Narrative This revision includes a request for undergraduate student funding only and will not result in changes to the original proposed work